New Chemical Tools for Covalent Drug Discovery

ABSTRACT
Development of covalent drugs for cancer therapy relies heavily on identifying the full spectrum of on- and off-
targets within the proteome, along with the specific site of inhibitor binding to each target. Currently we cannot
predict the set of targetable cysteines for a given inhibitor nor the potential for covalent labeling of off-target
proteins, which can lead to unintended toxicities. These limitations impede 'target discovery' during development
of new covalent inhibitors. Similarly, once a specific protein target has been identified as being selectively bound
by an inhibitor-candidate of interest, it is difficult to ascertain the fraction of target molecules in a cell or tissue
that are covalently bound by the compound ('target occupancy'). Target discovery and occupancy data can be
combined with toxicology and pharmacokinetic results to build more informative risk profiles to ensure that only
the most promising drug candidates are advanced and ultimately nominated for clinical trials.
The objective of our interdisciplinary team (Justin Kim, chemistry and chemical biology; Jarrod Marto, protein
biochemistry and chemical proteomics) is to synthesize and test first-generation reagents designed to advance
covalent inhibitor target discovery and target occupancy studies. Achieving our objectives will validate our
approach and pave the way for an intensive and iterative campaign of probe synthesis paired with
chemoproteomic analysis to systematically optimize our reagents. In the fullness of time we envision a complete
suite of chemoproteomic assay-specific reagents to facilitate target discovery and target occupancy studies.
Aim 1. To optimize new bioorthogonal reagents for proteome-wide inhibitor target identification. In this
aim we will further develop our bioorthogonal chemistry and rationally expand our library of alkylating scaffolds
suitable for cysteine profiling experiments. We will systematically assess the performance of our probes for target
discovery using recently characterized covalent inhibitors of kinases and deubiquitinating enzymes.
Aim 2. To develop multiplexed reporter probes to rapidly quantify covalent inhibitor target occupancy.
We will leverage selective fragmentation of our reporter probe scaffold to develop high-sensitivity, high-through-
put targeted mass spectrometry assays to quantify the occupancy of covalent inhibitors on their primary protein
target. We will carefully assess the performance of our cysteine alkylating probes as universal reagents for pull-
down-based (PD) target occupancy analysis, including linearity, accuracy, and limits of detection/quantification.
Successful completion of our objectives will provide an initial set of reagents with an extensible framework to
support future probe optimization campaigns by us and others in the field. Collectively the output of our program
will accelerate development of new covalent drugs for cancer therapy.

Public health relevance
Narrative Recent FDA-approval of new irreversible inhibitors for cancer therapy has renewed interest in drugs which exert their influence via covalent modification of protein targets. However, our inability to accurately assess the full repertoire on- and off-target proteins bound by covalent inhibitors, as well as the inhibitor occupancy of any given target, represent major obstacles to the expansion of covalent drug programs. Herein we develop a new modular platform to rapidly synthesize and test chemical tools for target discovery and target occupancy with the ultimate goal of accelerating development of new covalent inhibitors.